Development of novel malaria pre-erythrocytic vaccine antigens targeting Plasmodium sporozoite liver infection

Previously, using a phage peptide display library, our group has identified Plasmodium parasite ligands and
corresponding host cell receptors important for sporozoite-Kupffer cell interaction in the mammalian liver.
Using a similar approach, we identified the HP1 peptide, a structural mimic of a ligand that the sporozoite
uses to infect hepatocytes. Immunization with the HP1 peptide protects ~ 50 % mice from P. berghei
challenge. Using an anti-HP1 antibody, we identified Plasmodium Phospholipid Scramblase (PLS) as the
sporozoite ligand of hepatocytes and a potential vaccine antigen. We propose 1) to identify PLS protein
epitopes that function in hepatocyte recognition, for use as a vaccine antigen; and 2) to develop a tri-
functional vaccine antigen containing i) a sporozoite circumsporozoite protein (CSP) epitope, targeting liver
sinusoid binding, ii) a sporozoite GAPDH-related epitope, targeting sporozoite exit from the circulation via
Kupffer cell traversal, and iii) sporozoite PLS epitope, targeting hepatocyte infection. We expect that this
approach will lead to enhancement of the moderate protective efficacy of the most advanced RTS,S/AS01
malaria vaccine.

Public health relevance
Malaria is among the deadliest infectious diseases and kills an estimated half million persons every year. This project seeks to identify vaccine epitopes that target three critical stages of parasite infection of the liver. The findings may lead to the development of a novel and improved malaria pre-erythrocytic vaccine.